HIV-DART 2024

Abstract/ Project Summary
Thanks to advances in antiretroviral therapy, the face of HIV and AIDS has been gradually and meaningfully
transformed from a deadly disease, into a chronic condition that is managed with careful adherence to life-long
treatment regimens. The need for improved drugs, with fewer side effects, improved adherence, and more
favorable pharmacokinetics increases as the number of infected individuals on long-term therapy continues to
rise. Importantly, the quest for an HIV cure continues to gain momentum as we learn more about viral
reservoirs and mechanisms of viral persistence. HIV-DART is a biennial conference for physicians, clinicians,
nurses, scientists, and clinical researchers that will focus on the latest discoveries in these areas. Specific
Aims: 1. To gather cross-disciplinary professionals such as clinicians, health care workers, researchers, and
basic scientists together in an interactive workshop setting to share and discuss the latest developments in the
field of HIV; 2. To facilitate the neutral and balanced exchange of scientific knowledge with regard to antiviral
drug development, vaccine development, and recent progress in curative strategies; 3. To enhance the training
of young scientists such as graduate students and post-doctoral fellows and provide increased opportunities
for underrepresented scientists and health care workers through attendee scholarships. Educational
Objectives: 1. Advances in antiretroviral therapy, long-acting formulations, and injectable drugs for HIV; 2.
Novel approaches to suppress and eliminate HIV reservoirs; 3. HIV cure strategies; 4. HIV in the aging
population; 5. Novel vaccines and immunological therapies in development; 6. Treatment as prevention and
PrEP; 7. HIV co-infections with HCV, HBV, and/or SARS-CoV-2. Design & Methods: HIV-DART 2024 will
take place over 2.5 days, at a location that is easily accessed by both national and international delegates. The
program will include plenary lectures, oral abstract presentations, discussion panels, and a debate. This
ACCME-accredited program will provide ample time for formal and informal networking and discussion
amongst the delegates during the poster session, coffee breaks, and meal breaks.

Public health relevance
Project Narrative Since its first installment in 1998, HIV-DART has provided a strong forum for national and international HIV researchers and infectious disease healthcare professionals to learn about the latest developments in novel antiretroviral therapies and modalities. This biennial conference encourages young scientist participation through the provision of scholarships to oral abstract presenters and other underrepresented delegates. In line with previous years, HIV-DART 2024 will provide accredited Continued Medical Education sessions for physicians and clinicians, ensuring a positive impact on medical practices of the greater HIV and infectious disease global community.